COMBINED SODIUM FLUORIDE AND CALCIUM CITRATE THERAPY IN OSTEOPOROSIS

The purpose of this project is to determine whether or not the amount of bone in persons suffering from osteoporosis can be increased using a combination treatment program utilizing slow-release sodium fluoride and calcium citrate. Since this is a non-randomized study, only previously entered patients continue to be studied. New patients are entered into the randomized trials underway via sister projects.